TeleLine: Plug-n-Play Inline Respiratory Remote Data Acquisition System

Project Summary
One in five Americans live in a rural community served by rural hospitals yet only 1% of ICU resources are
available to these hospitals. When the level of care required by a patient exceeds the capabilities of the
admitting hospital, the patient is transferred to a better-equipped tertiary hospital. Approximately 800,000
patients require mechanical ventilation every year in the United States (pre-COVID). Treating mechanically
ventilated patients not only requires specialized equipment, but also specialized skills as well which are difficult
to find in rural settings. Our group proposes novel research to demonstrate the power of telemedicine in the
rural setting by extending the reach of pulmonary critical care specialists. By enabling pulmonary critical care
specialists at distant sites, rural hospitals can treat more patients without transferring them. Data suggests
patients who are transferred from rural hospitals to tertiary care centers suffer delays in care, adverse events,
and higher mortality. Unfortunately, due to high transfer rates, significant amounts of revenue are lost and
operating budgets at rural hospitals are generally inadequate to support replacement and integration of
cutting-edge ventilators to gain telemedicine capabilities. Our research and development is focused on
preparing a solution which can extend the geographic reach and enhanced remote capabilities of pulmonary
care specialists who are typically located in urban and suburban settings to those rural institutions while at the
same time protecting the hospital’s legacy investment in ventilator equipment. To achieve these goals, we have
developed an in-line respiratory circuit sensor (TeleLine) prototype that we will further refine for
commercialization and eventual in-field deployment. The TeleLine is a non-invasive sensing suite to any
existing ventilators and equipping them with both data logging and remote monitoring capability. The patient’s
respiratory response to mechanical ventilation can be captured locally and securely transmitted to a remote
site with appropriate expertise in pulmonary critical care. We will further develop the TeleLine in two aims: Aim
1) to refine the existing TeleLine prototype for plug-and-play, vendor-agnostic ventilator interfacing, and
ventilator data logging; and Aim 2) to develop and benchmark supporting data collection and machine learning
infrastructure for facilitating remote patient care. Successful completion of this project will enable a Phase II
program that enhances device manufacturability, clears critical benchmarking for initial device regulatory
approval, and further develops machine-learning assistance capabilities of the TeleLine system.

Public health relevance
Project Narrative Rural hospitals serve nearly 20% of the United States population with only 1% of Intensive Care Unit (ICU) resources contributing to worse outcomes for critically ill, rural patients. While telemedicine can improve ICU outcomes, tele-critical care providers as of yet lack real-time physiologic ventilator data. In this grant application, we propose the further development of the TeleLine, a connected plug and play ventilator circuit monitor device, through two aims: Aim 1) to refine the existing TeleLine prototype for plug-and-play, vendor-agnostic ventilator interfacing, and ventilator data logging; and Aim 2) to develop and benchmark supporting data collection and machine learning infrastructure for facilitating remote patient care.